Continued Clinical Development of a Novel Pleural and Tracheal Sealant

PROJECT ABSTRACT
A range of lung diseases and critical illnesses, including complications of mechanical ventilation, as well as
trauma can result in air leak from the lung (pneumothorax). These leaks often require immediate life-saving
measures to stabilize for subsequent reparative interventions. Continued care can further be complicated by
chronic air leaks (bronchopleural fistula, BPF) requiring need for prolonged chest tube drainage and/or invasive
surgery and can be difficult to manage. These all result in significantly increased morbidity, mortality, hospital
stays, health care costs, and other complications. However, at present there are only limited options for directly
repairing pleural leaks, particularly chronic leaks, and new therapeutic interventions are critically needed.
We have developed a novel sealant patch consisting of dopamine-conjugated methacrylated seaweed-derived
alginate (ALG-MA-DA). The patch has desired materials properties, including tailorable stiffness, elasticity, and
adhesive strength, and is easily transported and applied to the lung surface. We have further designed, tested,
and documented safety and efficacy in initial pre-clinical studies utilizing ex vivo and in vivo small and large
(rat/pig) models of lung injuries.
We now propose to further define optimal GMP-grade manufacturing, sterilization, and storage conditions, and
to further define longitudinal safety and efficacy in the small (rat) and large (pig) animal models of pleural injuries.
This will include assessing sealant patch efficacy with larger wounds and also assess efficacy of shelf-stored
patches. We will also engage with the FDA for development of initial clinical investigations and a Pre-Sub (Q)
meeting is scheduled for April 10, 2023. The studies will be done with our industry partner Akina Inc and
Accelerator partner CELLINK LLC.
The developed system will fall under the FDA category as a class III medical device given both its invasive
application and its use in supporting or sustaining human life. As such, the proposed Specific Aims are
consonant with the goals of the NIH Catalyze Program HL-23-014, “Product Definition Device Prototype Testing
and Design Modification”.
1. To define optimal sterilization, preservation, and storage conditions of ready-to-use research-grade patches
and apply this to manufacture and characterization of GMP-grade ALG-MA-DA patches
2. To further define ALG-MA-DA patch safety and efficacy in long-term rat and pig pleural injury models
3. To engage with the FDA and initiate an IND for initial clinical investigation.

Public health relevance
PROJECT NARRATIVE Acute and chronic air leaks resulting from lung injury or disease can result in significant mortality, morbidity, and healthcare costs, and can be difficult to treat resulting in a critical unmet need for new therapeutic approaches. We have developed a new pleural sealant (lung bandaid) and have compelling pre-clinical data in small and large animal models of pleural injury. The goal of the current proposal is to continue to develop further data in support of engagement with the FDA to develop an IND for initial clinical investigation.